New tools to probe iron and manganese homeostasis in bacterial and eukaryotic cells

Project Summary
With few exceptions, the enzymes that catalyze Nature’s most challenging and important reactions all require
metal ions for activity. Among the most important of these metals in organisms from bacteria to humans are iron
and manganese: nearly all organisms require iron for growth, and the few that do not require iron depend on
manganese instead. Cells carefully regulate the concentrations of the metal ions that they require through a
complex network of uptake proteins, export proteins, trafficking proteins, and protein- and RNA-based regulatory
systems. The proper function of all of these systems are essential to avoid potentially deleterious chemistry of
the “free” metal ions as well as inactivation of enzymes resulting from incorporation of incorrect metal ions. As a
result, mismanagement of the cellular free concentrations of iron and manganese has been connected with a
number of human diseases, in particular neurodegeneration. On the other hand, the ability of a host organism
(a human being) to disrupt metal management in an invading pathogen correlates with reduction of the virulence
of that pathogen. Therefore, a more detailed understanding of the mechanisms of iron and manganese
homeostasis in bacteria and humans has the potential to lead to new approaches to treat these diseases. An
important approach to study metal homeostasis involves design and application of metal-selective fluorescent
sensors – consisting of either small molecules, proteins, or nucleic acids – which are able to report on
concentration, localization, and dynamics of the metal ions within cells. Fluorescent sensors for metals such as
calcium and zinc have revolutionized our understanding of the biology of these ions. Unfortunately, few tools
exist to study iron and manganese within cells, a reflection of the inherent challenges associated with selectively
detecting an analyte that tends to bind weakly in biological systems. This research proposal outlines a
comprehensive program to develop selective fluorescent sensors for iron and manganese, using Nature’s
platforms for selective metal recognition, in order to probe novel mechanisms of metal regulation in bacteria and
in eukaryotic cells. The proposal uses detailed biochemical analysis of metal recognition by iron- and
manganese-binding proteins and nucleic acids to rationally design new sensors. These sensors are then
deployed to provide insight into outstanding questions in the field, such as the mechanism and consequences of
iron overload in pathogenic bacteria, as well as characterization of intracellular manganese trafficking systems
in yeast and human cells. These answers will not only increase our understanding of fundamental mechanisms
of selective metal recognition in biological systems but also potentially uncover new avenues for therapeutic
intervention.

Public health relevance
Project Narrative Nearly all organisms require iron for growth and survival, and the few that do not require iron depend on manganese instead. Mismanagement of cellular concentrations of these metals has been implicated in a variety of human pathologies, from bacterial infections to neurodegenerative disease. This research proposal seeks to develop selective fluorescent sensors for iron and manganese in order to probe mechanisms of metal regulation in bacteria and in mammalian cells, with the goal of uncovering new and potentially unique avenues for therapeutic intervention in these diseases.